Fine-resolution mapping of micro vasculature after placental transport of acoustic nanodrops

Project Summary/Abstract A fundamental question in developmental biology is how speciﬁc molecules and genetic pathways control mor- phogenesis during embryonic development. Recent studies have shown that many of the same molecules and genetic pathways affecting organogenesis are also involved in vascular development and patterning during an- giogenesis. A major challenge is to develop rapid, in vivo mouse-embryo imaging methods that provide the ability to analyze organ and vascular patterning with ﬁne resolution. The goal of this proposal is to establish the feasibility of transporting acoustic nanodrops (NDs) through the pla- centa in order to map vasculature of the embryonic mouse, in utero, with super-resolution, plane-wave ultrasonic imaging. Perﬂuorocarbon NDs can be vaporized by an acoustic excitation and converted to gas ﬁlled acoustic contrast agents. After vaporization, the NDs reach a size on the order of 1 m and appear as bright points in an ultrasound image. We will formulate ND compositions of different size, charge and perﬂuorocarbon core. We will evaluate ﬂuorescent ND compositions to determine which NDs, after injection into the maternal mouse tail vein, pass through the placenta into the embryonic circulation and select the most promising composition in terms of size and transport efﬁciency. We will quantify the acoustic pressures at which the selected NDs vaporize. The most promising ND in terms of vaporization threshold will be injected into the maternal tail vein of a mouse and, after entering the embryonic circulation, the NDs will be activated with an acoustic pulse. Plane-wave ul- trasound and super-resolution methods will then be utilized to detect and localize activated NDs at ﬁne-spatial and -temporal resolution as they move through the embryonic circulation. Feasibility of vascular mapping in a single plane will be evaluated. Because this approach relies on tracking point targets, the length scale that can be resolved, on the order of 20 m, is much less than the lateral beamwidth of the 18-MHz linear-array acous- tic ﬁeld. The ability to activate NDs that have passed through the placenta and to perform noninvasive, in utero contrast-enhanced imaging has high potential to revolutionize the way we study organogenesis and angiogenesis in widely utilized models of normal and abnormal embryonic development.

Public health relevance
Project Narrative The purpose of this study is to establish the feasibility of employing perﬂuorocarbon acoustic nanodrops to im- age mouse embryo vasculature in utero with super-resolution plane-wave imaging methods. This technique will enable mapping of the vasculature at ﬁne-spatial and -temporal resolutions, which will help improve our under- standing of how various factors (e.g., genetic, environmental, etc.) impact organogenesis and angiogenesis during embryonic development.